Mitochondrial deubiquitinase USP30 regulates cell metabolism-mediated miRNA biogenesis and microvascular inflammation

Abstract
Acute inflammatory diseases are life-threatening health conditions that are most often caused by bacterial
or viral infection such as Pseudomonas aeruginosa- or SARS-CoV-2-induced acute respiratory distress
syndrome (ARDS) and sepsis. ARDS and sepsis-related mortality remains at unexpectedly high levels due
to lack of effective pharmacotherapies. Hence, a new therapeutic strategy for ARDS and sepsis is needed.
Microvascular inflammation and barrier disruption play critical roles in the pathogenesis of acute
inflammatory diseases. A mitochondrial de-ubiquitinating enzyme, USP30, plays a vital role in regulation
of mitochondrial outer membrane protein homeostasis. USP30 has been considered as a potential target
for treating Parkinson’s disease and cancers; however, the role of USP30 in microvascular endothelial cells
(ECs) and acute inflammatory diseases has not been reported. In our preliminary data, we discovered that
inhibiting USP30 diminished EC dysfunction and reduced the severity of experimental lung injury.
Mechanistically, we discovered a non-canonical pathway of USP30 that links MAT2A stability, the S-
adenosylmethionine (SAM) cycle, DNA methylation, miRNA-30a-5p synthesis. Based on our
comprehensive preliminary data, we hypothesize that inhibiting USP30 preserves EC function by
modulating intracellular signaling cascades implicated in MAT2A stability, SAM production, DNA
methylation, and miR-30a-5p expression. We propose testing the hypothesis with the following Specific
Aims: Aim 1 is to determine if USP30 in the endothelium is a potential target for treatment of acute lung
injury. We will determine if inhibiting EC USP30 diminishes leukocyte cell adhesion to EC and
transendothelial migration and preserves EC barrier integrity. Further, we will determine if depletion of
USP30 in endothelial cells reduces severity of pseudomonas aeruginosa- or sepsis-induced experimental
lung injury. Aim 2 is to determine the molecular mechanisms by which inhibiting USP30 destabilizes
MAT2A, decreases the SAM production, and increases miR-30a-5p. We will determine if inhibiting USP30-
induced miR-30a-5p occurs through modulation of MAT2A stability in the SAM cycle, reduction of SAM
production and pri-miR-30 promoter methylation. Further, we will determine if miR-30a-5p regulates USP30
inhibition-mediated MDM2, MLC, and NFAT5 downregulation. Aim 3 is to determine if the protective effect
of USP30 inhibition occurs through modulating miR-30a-5p expression. We will determine if USP30
inhibition preserves EC function by modulating miR-30a-5p expression in HLMVECs. Further, we will
determine if EC USP30 depletion reduces severity of experimental lung injury through modulating miR-
30a-5p expression by using a cutting-edge RNA nanoparticle technology. Comprehensive understanding
of mitochondrial de-ubiquitinating enzyme inhibition-induced changes of cell metabolisms and EC function
is important for development of new therapeutic targets for treatment of acute inflammatory diseases.

Public health relevance
Acute inflammatory diseases are life-threatening health conditions that are most often caused by bacterial or viral infection such as Pseudomonas aeruginosa- or SARS-CoV-2-induced acute respiratory distress syndrome (ARDS) and sepsis. Microvascular inflammation and barrier disruption play critical roles in the pathogenesis of acute inflammatory diseases. The studies in this proposal will elucidate the effect of inhibition of a mitochondrial USP30 on preservation of endothelial function through modulating an undiscovered intracellular signaling cascade implicated in SAM cycle, DNA methylation, and miR-30a-5p expression.